Biochemistry, Cellular and Molecular Biology Program

PROJECT SUMMARY/ABSTRACT
The Biochemistry, Cellular and Molecular Biology (BCMB) Graduate Program has trained more than 700
scientists since 1972. BCMB serves as the major training program for seven basic science departments at the
Johns Hopkins University School of Medicine and is one of the oldest multidisciplinary graduate programs in the
country. There are 100 faculty members actively involved in research, teaching and as mentors. The
Departments that participate in the program are Biological Chemistry, Biophysics and Biophysical Chemistry,
Cell Biology, Molecular Biology and Genetics, Neuroscience, Pharmacology and Molecular Sciences, and
Physiology. An average of 22 students matriculate each year and obtain their Ph.D. in an average of 5.7 years.
The objectives of the BCMB program are: (1) to provide a broad and deep science curriculum; (2) to provide
longitudinal training in rigorous, reproducible and responsible experimental research; (3) to provide training in
professional skills; (4) to provide activities for trainees to explore career options; and (5) to recruit and support a
diverse student population in an inclusive environment. These objectives will be met through a rigorous
curriculum covering the first year of study that includes courses focused on macromolecules (energetics,
structure and function), molecular biology and genomics, genetics, organic mechanisms in biology, cell structure
and dynamics, and pathways and regulation. There is a new strong emphasis on bioinformatics and
computational skills throughout the coursework. There are multiple paper discussion courses extending from
years 1 through 3 to support training in rigorous and reproducible research. There are discussion courses that
focus on responsible conduct of research, in addition to department-based workshops as students advance in
their thesis work. Oral and written presentation skills are developed throughout training through workshops
targeting different specific tasks (oral exams, chalk talks, manuscript and proposal writing). Professional
development and career planning is an integral part of the program, occurring through workshops and courses
throughout the training period, as well as diverse internship offerings. Most students publish multiple research
papers and the training concludes with presentation of a public seminar and submission of the doctoral thesis.
BCMB graduates hold leadership positions at all levels of academia, government and industry. The success of
our students is fostered by an extraordinary level of collaboration and interaction among the faculty and trainees.
Special emphasis is placed on applying conceptual breakthroughs in basic science to problems relevant to
human health and disease. Here we request 25 training grant slots to appoint training grant eligible students
during their first two years in the program.

Public health relevance
PROJECT NARRATIVE The purpose of the Biochemistry, Cellular and Molecular Biology Graduate Program is to train outstanding scientists for diverse careers in biomedical research. This goal is achieved through a rigorous, broad-based curriculum and independent research in a basic science laboratory. This type of training is essential for understanding human disease at a fundamental level, and allows our students to enter the biomedical workforce where they contribute to breakthroughs in biology and medicine.